Behavioral Effects of Welfare Reform

The Personal Responsibility and Work Opportunity Reconciliation Act (PRWORA) of 1996, often referred to as welfare reform, ended entitlement to welfare benefits under Aid to Families with Dependent Children (AFDC) and replaced AFDC with Temporary Assistance for Needy Families (TANF) block grants to states. The broad goal of PRWORA was to reduce dependence on government benefits by promoting work, encouraging marriage, and reducing non-marital childbearing. The legislation represented a convergence of dissatisfaction with the welfare system on both sides of the political spectrum, with welfare participation becoming viewed by many as a cause of dependence rather than a consequence of disadvantage. The key strategy for reducing dependence was to promote work by imposing work requirements as a condition for receiving benefits as well as time limits on receipt of cash assistance. The basic argument was that labor force participation would break a culture of dependence by increasing self-sufficiency and reconnecting members of an increasingly marginalized underclass to the mainstream ideals of a strong work ethic and civic responsibility (Katz 2001). At the same time, there were concerns that some individuals would be illequipped to maintain stable employment (e.g., due to low job skills or disability) and that the pro-work regime would marginalize, rather than mainstream, those individuals by contributing to existing hardships (e.g., Katz 2001;Lichter &Jayakody 2002). Welfare reform has increased employment and decreased welfare caseloads as intended, but the success of the "work first" strategy has not been investigated with respect to a wide range of indicators of mainstream or marginal behavior such as adult educational acquisition, illicit drug use, crime, and civic participation. As the first stage of a larger project exploring all of these outcomes, we will estimate the effects of welfare reform on one important type of mainstream behavior-educational enrollment. Past research has found that returns to community college (both degree-granting and vocational programs) are about the same for returning adult students as for traditionalage students, and that each year of credit at a community college yields, on average, a 5 to 8% increase in annual earnings-a return similar to that from one year of a four-year college.

Public health relevance
Project Narrative Exploiting variation in welfare policy across states and over time and using relevant comparison groups, we will estimate the effects of welfare reform on adult women's educational attainment, as well as on crime, drug, use, and civic participation of women and youth. We will also explore the mediating effects of work and family structure. This research is necessary for understanding the extent to which the "work first" strategy under welfare reform has been successful at effecting deep-rooted changes in behavior, and more generally, for understanding the broad impacts of welfare reform.